Genetics and Cell Biology Training Program

Project Summary:
This is a new application to support a pre-doctoral training program in Genetics and Cell Biology at The
Rockefeller University, an institution with a rich history in these areas. The mission of the program is to provide
a diverse pool of trainees with the instruction, experience, and career development support needed for
successful careers in genetics and cell biology. Objectives of the program include recruiting outstanding
graduate trainees from diverse backgrounds to the training program and providing them with comprehensive
didactic training, state-of-the-art research skills, and professional skills needed for careers in the biomedical
science workforce. Incorporated into the training plan are recurring training in responsible conduct of research
and mechanisms to increase retention and reduce time-to-degree.
We propose to support 12 pre-doctoral trainees per year in their second and third year of training: 6 in year two
and 6 in year three. The applicant pool is outstanding, including many students with accomplished
undergraduate records, extensive research experience and a strong interest in genetics and cell biology. The
49 faculty trainers are accomplished scientists, including 3 Nobel laureates and 19 members of the US
National Academy of Sciences, with a shared interest and experience in graduate education. The
interdisciplinary nature of the program encourages trainees to perform collaborative work in various areas with
different faculty. Trainees would be mentored by the Program Directors; a Program Advisory Committee of
selected faculty for general curriculum and research advice; and a Faculty Advisory Committee, specifically
designed for each trainee to provide detailed experimental guidance. An External Advisory Committee will
evaluate the effectiveness of the program and provide advice on new initiatives.
Our past trainees have been highly successful, with most continuing in biomedical research careers. Upon
completion, we expect trainees to have diverse scientific knowledge, technical expertise, and professional
development skills necessary to become leaders in their chosen field.

Public health relevance
Project Narrative: The proposed training program will support the training of a diverse group of predoctoral students in genetics and cell biology, with direct implications for human health and disease. The training includes clinically relevant coursework and research opportunities and will prepare trainees for a range of careers in the biomedical workforce.